Determining Barriers Leading to Inferior Survival for Black and Hispanic Patients with Hodgkin Lymphoma: A Patient-Centered Study

Project Abstract
Although Hodgkin lymphoma (HL) 5-year relative survival exceeds 90%, Black and Hispanic patients face
inferior survival in childhood, adolescence and young adulthood (AYA), and as older adults. The gap in
knowledge for the mechanism explaining inferior survival reflects (i) the inability to provide individual social
factor data, (ii) the lack of postrelapse treatment data, especially stem cell transplant (SCT) data, and (iii) the
omission of survivorship care as a cause. There is a critical need to identify predictors of variation in treatment
and survivorship care leading to worse survival reported for Black and Hispanic patients with HL to create an
evidence-based framework upon which to design interventions to improve outcomes of HL patients of all ages.
This proposal’s overall objective is to determine how social factors may explain poorer HL survival outcomes
for Black and Hispanic patients. Our central hypothesis is that key and distinct social factors influence survival
for each age group, and these will be identified through the novel linkage of comprehensive longitudinal
databases: the Patient-Centered Outcomes Research Network (PCORnet, which provides longitudinal patient-
level electronic medical record and administrative claims data) and the Center for International Blood and
Marrow Transplantation Research (CIBMTR, which provides high-quality clinical and SCT data). The central
hypothesis will be tested by pursuing three specific aims in this mixed-methods study: 1) Examine differences
in the receipt and quality of HL treatment for initial diagnosis and relapse for those who have relapsed; 2)
Examine the receipt and quality of survivorship care; and 3) Examine diverse patients’ decision-making
experiences with upfront, relapse, and survivorship care using in-depth interviews with survivors recruited
through strategic partnerships. For Aims 1 and 2, a cohort of more than 26,000 patients diagnosed between
2010 and 2023, representative of the HL population by race, ethnicity, social factors, and age, will be evaluated
for differences in (i) anticancer therapy and (ii) post-therapy survivorship care by social factors stratified by the
aforementioned subgroups. For Aim 3, semi-structured, in-depth interviews of a sample of HL survivors and
caregivers enriched in Black and Hispanic representation will be conducted to understand the treatment and
survivorship decision-making process for patients and families through their lived experiences. The research
proposed is innovative because (i) the PCORnet and CIBMTR data linkage confronts knowledge gaps
regarding longitudinal care and postrelapse treatment and (ii) the proposed partnership with national patient
advocacy organizations for Aim 3 accrual achieves the intended representation of both Black and Hispanic
patients and AYAs. The proposed research is significant because it is expected to provide strong scientific
justification for informing policy and developing interventions to bridge inequities in care and outcomes borne
by Black and Hispanic survivors, particularly as more than 220,000 HL survivors live in the US today.

Public health relevance
Project Narrative The proposed research is highly relevant to public health because it evaluates mechanisms to explain inferior outcomes for Black and Hispanic survivors of Hodgkin lymphoma, as there are more than 220,000 Hodgkin lymphoma survivors alive in the United States. The three-aimed proposal utilizes quantitative data from longitudinal national electronic health records innovatively linked to stem cell transplant and qualitative data from patients’ and caregivers’ decision-making experiences with cancer treatment and survivorship care. The project is relevant to NCI’s mission and the National Cancer Plan because it aims to extend excellent outcomes of Hodgkin lymphoma for all survivors by leveraging existing data sources, fulfilling the National Cancer Plan Goals to (i) eliminate inequities, (ii) deliver optimal care, and (iii) maximize data utility.